Increasing Live Donor Kidney Transplantation Through Video-based Education and Mobile Communication

Project Summary
Living-donor kidney transplantation (LDKT) is the optimal treatment for end-stage kidney disease to increase
length and quality of life, yet it is vastly underutilized, putting thousands of transplant candidates at
unnecessary risk for premature death. Evidence indicates that transplant candidates need better access to
evidence-based education and outreach tools to overcome their substantial informational barriers and help
identify and recruit live donors from their social networks. The long-term goal is to devise an educational
strategy to increase access to LDKT and, in doing so, reduce kidney disease-related morbidity and mortality.
The objective of this R01 application is to increase receptivity to LDKT among transplant candidates through a
web-based educational intervention (KidneyTIME) previously developed by the Co-PIs. Although the proposed
intervention is evidence-informed and promising, it needs to be effectiveness-tested compared with a control
condition prior to larger-scale evaluation. Our central hypothesis is that transplant candidates will most often
engage their social networks with information about LDKT when presented with the KidneyTIME educational
intervention. The research study will pursue 3 specific aims: (1) determine the effects of KidneyTIME compared
to Usual Care to improve transplant candidate LDKT knowledge, attitudes, and outreach behaviors, (2)
evaluate the effects of KidneyTIME compared to Usual Care on potential live donor inquiries to donate, and (3)
identify and compare the effects of KidneyTIME versus Usual Care on activation of perceived social support
among transplant candidates when considering LDKT. For the first aim, validated survey measures will assess
LDKT knowledge, concerns, readiness, communication self-efficacy, and outreach behaviors immediately and
at 2-weeks, 6-months, and 12-months post-exposure. For the second aim, estimates of living donor inquiries at
12-months post-baseline will be obtained. For the third aim, multivariate regression models that assess
perceived social support simultaneously will explore optimal intervention components, dosage, moderators,
and interactions on live donor inquiries, and an embedded qualitative process evaluation will be used to
examine intervention sustainability, extent to which it is contextually situated, and potential refinements to the
intervention. The proposed research is innovative in that it shifts the current paradigm of intervention research
to increase access to LDKT from a primary reliance on synchronous education to transplant candidates
towards an asynchronous learning approach that facilitates education of others about LDKT. The proposed
research is significant in providing web-based education that activates social network outreach—an approach
that ultimately may be necessary to increase access to LDKT. Our expected outcome is knowledge of how to
effectively reach candidates and their social network with education about LDKT to increase access to LDKT.
The proposed research is relevant to the National Institute of Diabetes and Digestive and Kidney Diseases’
mission to conduct and fund research on kidney diseases to improve people’s health and quality of life.

Public health relevance
Project Narrative A crisis in the United States is that nearly 100,000 individuals are on the list for a kidney transplant and almost half die or become too sick while waiting because of a profound shortage of kidneys. Millions of healthy Americans are potentially willing and able to donate a kidney, but due to knowledge and communication barriers, the tremendous potential of live donation to meet the need for kidneys remains unrealized. To address the problem, we developed a novel educational and communication solution for transplant candidates to increase their access to live donor kidney transplantation that, once tested, will be disseminated nationwide.